AFC-HDPT

HDPT Project Summary
A disaster, by definition, is an unexpected destructive event that brings harm and damage to a
community. The disaster may be natural such as hurricanes, tornados, floods, wildfires, or earthquakes. Or
they could be man-made such as an industrial accident, active shooter event, terrorist incident with weapon of
mass destruction While the community members often feel powerless to control the disaster, they can take
steps to prepare for their response if it occurs. AFC proposes to use funds from the NIEHS Worker Training
Program’s Hazmat Disaster Preparedness Training Program (HDPT) to provide preparedness training to public
safety responders in the southeast US and to Native American tribes throughout the country. The proposed
project will deliver quality training focused on safety for first responders to a disaster, whether natural or man-
made. This project will target public safety (fire, law, EMS, EMA) responders with training that helps them
recognize hazards, assess response actions, and bring some order to the chaos of the disaster scene.
Disasters often become mass casualty incidents (MCI) and responders may need to triage their limited
resources to do the most good. Also, unfortunately, these MCI events may be “man-made” acts of terror in
which the perpetrator of violence is still at the scene. AFC proposes to bring Hostile Event Response training
that teaches enhanced situational awareness and survival as well as life-saving tactical “stop-the-bleed” care in
an active shooter or improvised explosive device event. In the proposed 5-year project, AFC projects to bring
25 classes to 500 Native American trainees in 4,000 contact hours. We project to deliver 50 courses to 1,000
public safety trainees in 8,000 contact hours. We expect to support an additional 25 courses for 375 trainees
from both populations in 1,500 contact hours of secondary training. In total, AFC plans to hold 100 courses for
1,875 trainees in 13,500 contact hours of quality training.

Public health relevance
Component Project Summary Not Required